MOLECULAR AND CELLULAR CONTROL OF ANGIOGENESIS

ABSTRACT
Endothelial cells (EC) mount distinct cellular responses to signaling inputs as primitive vessel networks expand via
sprouting angiogenesis. This heterogeneity in cellular behaviors is achieved by differential signaling of key
pathways such as VEGF-A and BMP. Underlying differences in signaling is EC heterogeneity at the level of gene
expression and post-translational protein regulation. We define EC heterogeneity as distinct cellular behaviors in
response to either molecular or mechanical signals, accompanied by variation in expression profiles and regulation
of key pathway regulators. My lab has contributed to understanding how VEGF-A and BMP signaling contribute to
EC heterogeneity and how Notch co-ordinates these pathways. Heterogeneity is lost as vessels respond to flow-
mediated signals and remodel, and vessels “reactivate” to sprout and form new networks during physiological
wound healing. These observations lead to several questions whose answers will impact our basic understanding
of blood vessel formation and function, and help understand cardiovascular diseases. Our goals going forward are
to investigate developmental EC heterogeneity, to examine how heterogeneity is lost as vessels remodel to
homeostasis, and to test the novel hypothesis that reactivation of developmental EC heterogeneity contributes to
wound healing angiogenesis. We will use both models and tools that we've developed and successfully used to
date, and also incorporate new state-of-the-art approaches and tools to extend the impact of our findings beyond
early sprouting angiogenesis. Our over-arching hypothesis is that EC heterogeneity is promoted by low or absent
flow-induced shear stress, and repressed when shear stress reaches a critical threshold(s) by transitions in
regulation of signaling pathways. We further posit that wound healing angiogenesis is promoted by reduced shear
stress downstream inflammation-induced tortuous vessel formation. We will focus on the respective roles of VEGF-
A and BMP signaling in these processes. This new knowledge will fill critical gaps in our knowledge of how EC
achieve this remarkable transition from heterogeneous outputs to homeostasis to reactivation. This new knowledge,
in turn, will allow us and others to examine more precisely how dysregulation of EC transitions contributes to
disease.

Public health relevance
PROJECT NARRATIVE Differential regulation of growth factor signaling in endothelial cells that line blood vessels is important for formation of blood vessel networks during embryonic development. Once blood vessels form, this differential regulation is equalized among endothelial cells and reduced so vessels can function as conduits for oxygen and nutrients. However, vessels can respond quickly to reinitiate differential signaling and form new vessel networks in some situations, for example during wound healing. This work will study those states, ask how endothelial cells respond appropriately, and determine what changes during the transition periods lead to different signaling outcomes, thus setting the stage for new ideas for therapeutic interventions in diseases involving blood vessels.